A Short Course for Creating Integrative Oncology Leaders

ABSTRACT
The primary aim of this proposal is to improve the quality of life for people diagnosed with cancer by educating
a multi-disciplinary group of oncology professionals who have the knowledge and skills to act as leaders for the
safe and evidence-based integration of integrative therapies into conventional oncology care, education, and
research. Around 46% of people with cancer already use some type of integrative therapies. Despite the high
utilization of integrative therapies by people with cancer and the growing body of evidence on these therapies,
there are currently no comprehensive training programs for oncology professionals. To address this gap, we
previously developed the NCI-funded R25 Integrative Oncology Scholars (IOS) Program, a course to teach
evidence-base integrative oncology to a multidisciplinary group of oncology providers including physicians,
advanced practice providers, social workers, and psychologists. This course was able to significantly increase
knowledge and skills in key integrative oncology topics, while also leading to a substantial number of new
integrative oncology educational, research, and clinical initiatives. This proposal seeks to continue and expand
on our original Specific Aims by: 1. Train an additional 125 integrative oncology leaders (25 participants per
course x 5 courses = 125) via the short-course developed in our NCI-funded R25; 2. Increase the professions
eligible to participate to include pharmacists and enrich the curriculum to contain more content focused on
dietary supplements and herbal medicines; 3. Create partnerships between oncology leaders and integrative
practitioners within their communities; 4. Evaluate the impact of this short-course by measuring the process
and outcomes of the various educational activities over the course, and measuring the implementation and
outcomes of the capstone projects initiated by participants at their home institutions after completion of the
program; and to 5. Disseminate the findings through peer-reviewed journals, presentations at professional
meetings, and through both conventional and integrative oncology networks and associations. A variety of
evidence-based educational strategies (e.g., virtual courses, Web-based and print media) will be used to
achieve the largest impact and to enhance project sustainability. Extensive process and outcome evaluation
strategies will be used to measure the effectiveness of these educational efforts.

Public health relevance
NARRATIVE There are over 18 million cancer survivors in the US today and almost half of these cancer survivors are utilizing integrative therapies at some time after their cancer diagnosis. Despite the high utilization of integrative therapies by people with cancer and the growing body of evidence on these therapies, there are currently no limited training programs for oncology professionals to prepare them to evaluate the evidence and use of integrative modalities and limited incorporation of evidence-based integrative therapies into oncology practice. This proposal would continue, enhance, and expand a successful course in evidence-based integrative oncology by training an additional 125 oncology professionals to become integrative oncology leaders in their communities and home institutions, thus helping to provide better integration of care and improve the quality of life of cancer patients.